AIRWAY INFLAMMATION &MEDIATORS IN CHRONIC BRONCHITIS

The purpose of this study is to characterize the composition of airway secretions in patients with CB both during periods of relative clinical stability during bronchitic exacerbations.